Hypoxically stored whole blood--evaluation of platelet activities under hypoxic storage conditions

Whole blood [WB] transfusion is an effective therapy used to reduce the large number of
preventable deaths from hemorrhagic trauma. The long-term objective of this project is to develop a
modernized WB storage platform that reduces initial oxygen content and maintains an oxygen-managed
environment during refrigerated storage in order to provide higher quality red blood cells (RBCs) for
efficacious oxygen delivery and shock reversal, while maintaining bioequivalence in hemostatic and
platelet (PLT) activity compared to conventionally prepared WB. To reduce waste and enable wide-
spread adoption of WB, the proposed platform will include a novel WB additive solution, as well as a bag
and an RBC additive solution to recover and store RBC for 6 weeks from expired WB, as the RBCs have
a longer shelf life.
Unlike the RBCs, PLTs contain mitochondria and rely on oxidative phosphorylation both in vivo and at
room temperature during storage for their viability. PLT metabolism at 1-6°C is significantly reduced, and the
cytochrome oxidase in mitochondria is known to have a very low Km. Unfortunately, the extensive preliminary
in vitro data which has been collected to date does not provide a clear answer regarding the effects of stable
low oxygen tension (~10-20mmHg) on PLT hemostatic function.
The goal of this Phase 1 proposal is to obtain definitive data supporting the hypothesis that with its
reduced metabolic demands, the hypoxic RBC storage condition will provide adequate O2 tension to sustain
PLT’s hemostatic function, which would enable the project to proceed. The feasibility of this project will be
critically tested in this Phase 1 study by making hypoxic WB using an existing hypoxic RBC processing
system and tested in a small animal model study to compare the hemostatic function of conventionally
and hypoxically stored WB. Additionally, an in vitro study examining status of activation and activatability
of PLT under rejuvenated conditions mimicking the transfused state.
If the milestone of Phase 1 is successfully reached, the development of both a novel hypoxic WB
storage platform with a newly formulated additive solution for the WB collected in CPD and a RBC storage
solution enabling a full 6-week shelf life for hypoxic RBC recovered from unused WB will begin. For both
solutions, a successful metabolomics based high-throughput additive screening method, developed under
separate SBIR Phase II grant for the screening novel hypoxic RBC additive solution, will be utilized.

Public health relevance
While whole blood is already being used both in on-site pre-hospital care, during transport and in emergency rooms to reduce preventable deaths from hemorrhaging, it has only recently been recognized as the first-choice transfusion material for saving victims of severe bleeding and resulting shock. However, modern blood banking has primarily focused on blood components (red blood cells, platelets and plasma), resulting in a lack of development and innovation when it comes to whole blood processing and storage. The proposed storage platform intends to modernize whole blood storage by providing increased efficacy of oxygen delivery and hemostatic function, as well as eliminating unused whole blood waste, often caused by its shorter shelf-life when compared to red cells, by recovering red cells for further storage and transfusion.